Third Coast Center for AIDS Research

PROJECT SUMMARY
THIRD COAST CFAR OVERALL RESEARCH
The Third Coast Center for AIDS Research (TC CFAR) partners Northwestern University, the University of
Chicago, and the Chicago and Illinois Departments of Public Health. Key community organizations include
Howard Brown Health, AIDS Foundation of Chicago, Center on Halsted, AllianceChicago, and many others.
The Third Coast CFAR will “Make big plans; aim high in hope and work (Daniel Burnham).” The TC CFAR
Cores provide services and assays to enable all fields of HIV research to contribute to ending the epidemic
(Clinical Sciences Core; Behavioral, Social, and Implementation Sciences Core; Viral Pathogenesis Core), as
well as leadership, communication, networking, seed funding, and mentoring (Administrative and
Developmental Cores). Each Core supports the Innovation and Implementation for Impact on Ending the HIV
Epidemic Scientific Working Group (EHE SWG). The EHE SWG and the Cores help teams of biomedical and
behavioral researchers engage the community through the formation of trans-institutional and trans-disciplinary
collaborations. Additionally, TC CFAR recognizes it is also important to creating career pathways for
Underrepresented Minorities (URM) in the behavioral, health services, social, and/or translational sciences in
order for them to develop successful and impactful careers in research on minority health and health disparities
specifically focused on HIV. Therefore, by addressing the NIH HIV/AIDS Research Priority, “Research training
of the multidisciplinary workforce required to conduct High Priority HIV/AIDS or HIV/AIDS-related research,” we
propose a new TC CFAR Core to specifically address this Priority. The Diversity, Equity, and Inclusion Program
Core (DEIPC) is being proposed to advance the successful Program in Intersectional BIPOC SGM-focused
HIV Science.

Public health relevance
Modified Public Health Relevance Section The Implementation Science Coordination Initiative seeks to maximize the value of implementation science (IS) in the national Ending the HIV Epidemic plan by: (1) supporting high-quality IS in funded projects by providing technical assistance from experts on IS concepts and methods, and (2) creating opportunities for local knowledge to become generalizable knowledge by encouraging the use of shared frameworks and measures, synthesizing data across projects, and promoting collaboration. In collaboration with the Regional Consultation Hubs (RCH), ISCI will expand its infrastructure as a national resource to guide the field of HIV IS.